Costamere Defects in Muscular Dystrophies

PROJECT SUMMARY/ABSTRACT
While abundant skeletal (ask-actin) and cardiac (aca-actin) actin isoforms are famous for their essential role in
striated muscle contraction, low abundance non-muscle “cytoplasmic” actin isoforms (bcyto- and gcyto-actin) are
also emerging as important in the maintenance of specialized structures (and functions) in normal and
diseased skeletal muscle. During this project, we generated and characterized muscle-specific mouse lines
either lacking or overexpressing bcyto-actin or gcyto-actin to understand their endogenous functions and role(s) in
dystrophin-deficient muscular dystrophy. Interestingly, each bcyto-actin or gcyto-actin single knockout develops a
qualitatively similar phenotype characterized by a progressive myopathy with significant myofiber
degeneration/regeneration and muscle weakness. We have shown that skeletal muscle-specific
overexpression of bcyto-actin or gcyto-actin in dystrophin-deficient mdx mice affords significant protection from
eccentric contraction-induced force drop while overexpression of a C272A mutant of gcyto-actin affords no
protection. These and other data suggest that eccentric contraction drives a rapidly-reversible, reactive
oxygen species (ROS)-mediated inhibition of sarcomeric contractility that may function to protect dystrophic
muscles from damage caused by repeated, high force contractions. Our new preliminary data show that
muscle-specific ablation of bcyto-actin or gcyto-actin from wildtype muscle results in eccentric contraction-induced
force drop that is reversed by the nonspecific antioxidant N-acetylcysteine. Finally, we have obtained new
data suggesting that gcyto-actin is important for repair of membrane damage. Going forward, we will make use
of our unique animal models, isoform-specific reagents, and biochemical and physiological methodologies to
address new fundamental questions about cytoplasmic actins in normal skeletal muscle function and in
dystrophin-deficient muscular dystrophy. In aim 1, we will identify the sources of ROS contributing to eccentric
contraction-induced force drop in dystrophic mdx skeletal muscle as well as the downstream targets of ROS
that ultimately inhibit force production. In aim 2, we will investigate the role of oxidative stress in driving the
myopathy and eccentric contraction-induced force drop associated with genetic ablation of bcyto- or gcyto-actin in
skeletal muscle. In aim 3, the interplay between cytoplasmic actin isoforms and ROS in membrane repair will
be investigated using state-of-the-art imaging approaches to analyze muscles from the same mouse lines
used in aims 1 and 2. The results of the proposed studies will further delineate the unique and important
contributions of cytoplasmic actin isoforms to the function of normal and dystrophic skeletal muscle.

Public health relevance
PROJECT NARRATIVE We have established several unique lines of mice that enable us to elucidate the important functions of low abundance cytoplasmic actins in normal and diseased skeletal muscle. Of greatest immediate relevance to public health, we propose experiments that will mechanistically explain the dramatic, but reversible muscle weakness in dystrophic muscle exposed to lengthening, or eccentric contractions. While protection from eccentric contractions is well accepted as proof-of-concept for new therapies to treat muscular dystrophies, the cause of weakness is poorly understood. We are proposing to elucidate the mechanisms through which each type of actin contributes to muscle cell maintenance to provide the foundation for therapy development.